Social Media Discrimination, Cardiometabolic Health Behaviors, and Social Protections among Sexual and Gender Minorities

PROJECT SUMMARY
Cardiovascular disease (CVD) continues to disproportionally impact sexual and gender minorities (SGM)
compared to non-SGM. Further, because young SGM engage in harmful cardiometabolic health behaviors
(CHB; i.e., dysregulated sleep, physical inactivity, tobacco use, and alcohol use) and experience poorer mental
health at higher rates than non-SGM, interventions are necessary to reduce harmful CHB and poor mental
health before CVD occurs. A key social determinant of harmful CHB and poor mental health among SGM is
exposure to racial, sexual orientation, and gender discrimination. However, as young people are spending
more of their time online, there is a clear gap in our current understanding of how discriminatory features (e.g.,
racial discrimination) of frequented online spaces influence harmful CHB and mental health among SGM.
Further, there is an unmet need to understand the role of protective factors (e.g., online community support) in
the association between online discrimination and CHB and mental health. Therefore, to create culturally
relevant CVD prevention interventions for SGM, we must first understand the ways in which discrimination is
experienced in relevant online spaces (e.g., social media) and how this, in turn, is associated with CHB and
mental health. The proposed work builds on research delineating the multiple environments at which
individuals can experience discrimination, including in physical (e.g., perceived discrimination) and online (e.g.,
a racist post on Twitter) environments. This interdisciplinary team includes a collaboration with the National
Internet Observatory (NIO) to understand individual-level exposure to discrimination in online spaces as well as
exposure to discriminatory online sentiment tied to the places SGM frequent using sentiment analysis with
Twitter data matched to GPS activity spaces method over a 30-day study period. Results of this study will distill
the precedents and characteristics of the online environments defining the association between discrimination
and harmful CHB and mental health among SGM. Specifically, this study aims to evaluate; 1a) the association
between direct daily exposure to online discrimination based on race, sexual orientation, and gender in one’s
social media feed and harmful CHB among diverse SGM; 1b) the association between exposure to place
based discriminatory climate and harmful CHB among SGM; 2) the association between online discrimination
and place based discriminatory climate on daily mood and stress; and 3) social protections (e.g., online
support) that mitigate the association between exposure to individual level social media discrimination, harmful
CHB, mood and stress among SGM. This study is innovative as it uses novel multi-level measurement of
online discrimination, social protections, and CHB among diverse young SGM, who are historically
underrepresented. The significance of this work includes the creation of tailored harmful CHB interventions for
diverse SGM, including smartphone-based triggering of interventions to aid in healthy coping behaviors after
online discrimination is experienced in real time.

Public health relevance
PROJECT NARRATIVE Evidence indicates that race/ethnicity-, sexual orientation, and gender-related discrimination is linked to increased harmful cardiometabolic health behaviors (CHB; e.g., sleep, physical activity, and tobacco and alcohol use). However, there is limited research demonstrating the influence of online discrimination, a critical social determinant of health, on CHB among diverse groups of SGM. Our novel multi-method study design will illuminate how discrimination operates in online environments and physical spaces, as well as highlight key protective factors, which can be used to better distill risk and inform targeted mediums for harmful CHB prevention interventions among SGM.